Computational Methods for Gene Discovery, Genome Annotation, and Genome Assembly

Project Summary
Thousands of new human genomes are being sequenced each year in efforts to understand the genetic causes of
human diseases, and thousands of animal and plant genomes are being sequenced to answer a broad range of
biological questions. In parallel with this increase in whole-genome DNA sequencing, RNA sequencing has
exploded as well, due to its power to characterize gene expression in a multitude of cell types and conditions,
and to its potential to discover new genes and new splice variants. These enormous data sets require highly
efficient and accurate computational methods for analysis, and they also present opportunities for discovery.
To properly analyze the many diverse humans being sequenced, we need accurate, comprehensive catalogs of
genes and transcripts, and we also need to move beyond our reliance on a single reference genome that is
missing much of the variation found in the human population. We propose to address these challenges in
multiple specific ways: first, we will develop new and improved gene discovery and genome annotation
methods. This effort will include development of new algorithms for recognizing splice sites and protein-coding
regions; a new eukaryotic gene finder based on a convolutional neural network; expansion of our strategy for
using protein structure prediction to identify functional protein isoforms; and a new whole-genome annotation
pipeline that will make extensive use of RNA-seq data to find both coding and noncoding genes and transcripts.
Second, we propose to extend and enhance the CHESS (Comprehensive Human Expressed SequenceS)
database, the only human gene database that has direct evidence of gene expression associated with nearly all
of its genes. This effort will include mapping CHESS onto the complete T2T-CHM13 human genome,
enhancing the value of CHM13 as a new human reference, and mapping CHESS onto multiple other individual
human genomes. Our effort to expand the database will include analysis of many thousands of proposed novel
genes and transcripts proposed from other sources, where we will use a combination of protein structure
prediction, transcriptional evidence, evolutionary conservation, and ab initio gene prediction methods to
evaluate these for inclusion in CHESS. We will also create an ancillary searchable database, CHESS+, that will
contain millions of transcripts that have been assembled but not yet included in CHESS, as a community
resource for gene discovery. Third, we will build upon existing high-quality draft assemblies to assemble gap-
free versions of multiple new individual human genomes, chosen to increase the diversity of those previously
published. We will develop an improved cross-genome annotation mapping system that will use both DNA and
protein alignment, and use this system to annotate all of the new human genomes, which we will then compare
to identify mutations affecting gene-containing regions. Finally, we will apply our latest genome assembly
decontamination methods to identify contaminating DNA, which currently affects thousands of published
genomes, and release corrected versions of all genomes in which we find contamination.

Public health relevance
Project Narrative Many biomedical researchers use high-throughput DNA sequencing to study human disease and biology, and to do so they rely heavily on the human genome sequence and its annotated genes. The annotation and analysis of these very large, complex sequence data sets requires highly sophisticated, efficient software programs that can assemble DNA into genomes, assemble RNA into transcripts, evaluate the quality of different splice variants and protein isoforms, and use these results to create and improve genome annotation. This project will develop new algorithms, software, and data that will provide researchers with the necessary tools to address disease-related biological questions in humans and a wide range of other species.